THE CONTRACTOR SHALL SUPPORT AND IMPROVE NIAAAS ABILITY TO PROVIDE ACCURATE, RELEVANT AND UP-TO-DATE INFORMATION ON THE NIAAA WEBSITE.

The Contractor shall support and improve NIAAA’s ability to provide accurate, relevant and up-to-date information on the NIAAA website by creating appropriate content for audiences of the NIAAA website; revising and maintaining content to be scientifically accurate; ensuring (with guidance from the NIAAA Information Technology Branch [ITB]) that site, infrastructure and security measures are current and appropriate; providing a professional and functional web design optimized to serve NIAAA’s online audiences; troubleshooting and correcting any problems or errors that may arise.